Molecular and cellular mechanisms of inhibitory synapse development

The goal of the proposed research is to discover new mechanisms underlying the development
of hyperactive neuronal networks in the brain. Hyperactivity of neuronal networks due to the loss
or impaired function of inhibitory neurons can lead to neural dysfunctions and seizures. Both
impaired inhibition and glial dysfunctions have been linked to several neurodevelopmental
disorders including autism. Autism is an increasingly prevalent neurodevelopmental disorder
that affects approximately 1 in 59 children in the United States. We hypothesize that ephrin-
B/EphB receptor signaling controls the development of inhibitory networks by regulating the
interactions between pyramidal neurons and parvalbumin-expressing (PV) cells that are critical
for normal development. Premise of the study is supported by our new and unexpected
discovery that implicated astrocytic ephrin-B1 and Ephrin-B/EphB receptor signaling in the
development of connections between inhibitory PV cells and excitatory pyramidal cells in the
hippocampus. Our preliminary findings also show that loss of astrocytic ephrin-B1 increases
susceptibility to seizures and reduces sociability in mice. As genetic studies have linked de novo
variants in gene encoding EphB2 receptor with autism spectrum disorders (EPHB2 gene is
identified as a strong candidate with score 2 in SAFARI database), this study may also
contribute to our understanding of the pathophysiological mechanisms of these brain disorders.
We will test our hypothesis in three specific aims: Aim 1 will determine if EphB receptors
expressed in PV and SOM cells negatively regulate inhibition of CA1 pyramidal neurons by
examining the effects of PV- and SOM-specific ablation of EphB2 and EphB1 on the inhibitory
synapse development in the hippocampus during critical developmental period using
biochemical, immunohistochemical and optogenetic approaches. Aim 2 will determine the
mechanism of EphB signaling in regulating inhibitory synapse formation by establishing the role
of the neuronal ephrin-B/EphB signaling in inhibitory synapse formation. Aim 3 will test if
astrocytic ephrin-B1 positively regulates inhibitory synapse formation on pyramidal cells through
the displacement of EphB receptors from PV boutons. The proposed study will further our
understanding of the mechanisms which lead to neurodevelopmental disorders and will allow us
to discover novel interventions for treating these disorders through targeting EphB receptor
signaling and astrocytes during specific developmental period.

Public health relevance
Project Narrative: This study will address critical gaps in knowledge, including the mechanisms of inhibitory synapse formation and the role of astrocytes in inhibitory synapse development in the hippocampus. Since impaired inhibition and deficits in inhibitory interneurons are thought to underlie the development of hyperactive neuronal networks in neurodevelopmental disorders such as autism spectrum disorder, schizophrenia, and epilepsy, the proposed work may lead to the development of novel therapeutic targets to treat neurodevelopmental disorders. Proposed studies will utilize unique mouse models, state-of-art optophysiological analysis and imaging approaches, biochemical studies and translationally relevant video-EEG monitoring for seizures which we have used to evaluate epileptogenicity during developmental dysregulation of interneuronal circuits.